Digital Phenotyping of Nonalcoholic Fatty Liver Disease

1
2 PROJECT SUMMARY/ABSTRACT
3
4 One of the most critical gaps in management of nonalcoholic fatty liver disease (NAFLD) is the lack of effective
5 methods of early identification in the population. The objective of this study is to leverage data and analytics to
6 improve healthcare outcomes by early detection and risk stratification of NAFLD, before onset of liver-related
7 complications. Artificial intelligence applications in large electronic health records have the potential to identify
8 disease traits before onset of disease. The central hypothesis of this proposal is that targeted screening with
9 machine-learning models applied to large integrated healthcare datasets can identify individuals with NAFLD
10 and, more specifically, those with a progressive phenotype. We will test the central hypothesis in 2 specific
11 AIMs. First, we will train a machine learning model of NAFLD prediction using multiple longitudinal data points
12 of all health-care encounters of a well-characterized population-based cohort of individuals diagnosed with
13 NAFLD in reference to individuals without NAFLD from the general population. We hypothesize that
14 unsupervised machine learning can identify complex processes and patterns without a human's guidance and
15 discover early comorbidity clusters (“latent traits” present prior to NAFLD development) that reflect a phenotype
16 at risk to develop NAFLD later in life. Second, we will test and optimize the model for the prediction of patient
17 outcomes (development of cirrhosis, liver-related complications and death) in the NAFLD cohort. We
18 hypothesize that machine learning approaches could be used to further stratify patients into subgroups with
19 different disease trajectories, with the goal of identifying those individuals at risk of progressive NAFLD and
20 liver-related outcomes. The research proposed in this application is innovative because it expands the
21 analytical toolbox beyond conventional methods to identify individuals with NAFLD using all health-encounters
22 of a large, well-characterized population-based cohort with long follow-up. This proposal is significant because
23 it addresses a critical need of identification and management of the most prevalent chronic liver disease and
24 offers a practical solution to large scale implementation of screening and risk-stratification strategies using
25 routinely collected data. The ultimate goal of this proposal is to improve the population health in obesity-
26 associated diseases.

Public health relevance
PROJECT NARRATIVE This proposal will use innovative statistical methodology to improve the understanding of factors that predict an individual’s risk to develop nonalcoholic fatty liver disease and liver-related complications using routinely collected data available during the health care course of an individual. The development of effective and accessible tools to predict the risk of future development of liver disease will enable timely intervention to prevent the disease and reduce the burden of illness and mortality associated with obesity. Hence, the proposed research is critically important and relevant to the public health in a disease which affects a quarter of the adult population in the United States.